Modernization of a Shared-use Gnotobiotic Animal Core

PROJECT SUMMARY
The Gnotobiotic Animal Core (GNAC) is a specialized mouse care facility that is shared by investigators within
and outside of the University of Washington (UW). It is located in the specific pathogen free (SPF) vivarium in
the Health Sciences Buildings at UW and occupies ~1750 sq ft consisting of four separate rooms. It is managed
by two faculty members and highly trained GNAC Staff in the Department of Comparative Medicine. The GNAC
is a complete research support facility: We create and care for gnotobiotic and germ-free mice housed in the
core and provide technical support for diverse gnotobiotic research needs. A particular strength of the core is
that new investigators can conduct small pilot projects by using the ready-to-go expertise of GNAC staff even if
they do not have the extensive training needed for such studies. The GNAC has been operational for over seven
years, and during this period, more than forty investigators from fifteen different research groups have used the
GNAC. Over twenty publications have been generated with support from twenty-three federal grants and twelve
private foundation/institutional grants. GNAC utilizes two housing systems: Flexible-film isolators are used for
breeding and maintenance of various strains of GF mice, and isopositive cages are used for mice during
experiments. The isopositive cages are highly specialized, air-tight, HEPA filtered, bioexclusion cages (ISOcage
P caging manufactured by Tecniplast). When paired with using a biosafety cabinet and sterile technique, the
isopositive cages offer a more user-friendly alternative to isolators for investigators to maintain and manipulate
gnotobiotic mice. The goal of this application is to retrofit existing ISOcage P cages with a Digital Ventilated
Cage Rack Environment Monitoring (DVC REM) system. The DVC REM system will monitor cage- and rack-
level environments as well as global animal activity within each cage continuously. This modernization will greatly
enhance several experimental and husbandry-related aspects of gnotobiotic research using mice: 1) improved
experimental rigor, reproducibility and translation of experiments, resulting in reduced number of research
animals needed to address complex research questions; 2) improved animal welfare by providing 24/7
monitoring that will alert investigators to problems with animal health or the caging environment; and 3) improved
time management for GNAC staff during animal husbandry practices by streamlining scheduling of animal care-
related tasks and preparing and rotating supplies. Successful completion of our proposed plan will broadly
benefit all investigators using the facility by helping to maximize the use of limited resources and to improve
reproducibility in animal research by providing unprecedented continuous monitoring of environment and animal
activities.

Public health relevance
PROJECT NARRATIVE We seek to improve public health by modernizing the gnotobiotic animal core (GNAC) facility that serves investigators studying effects of the microbiome in health and disease using gnotobiotic mouse models. The proposed upgrade to a comprehensive digital monitoring system for the existing animal caging system will streamline animal care and maintenance. In addition, the proposed modernization will greatly benefit all GNAC users by providing previously unavailable animal monitoring data thus improving animal welfare and reproducibility in research conducted in the core.